METABOLIC FUELS AND HORMONES

This project examines the pathophysiology of glucose homeostasis (and other nutrients) in subjects with hypoglycemic disorders. The role of insulin, glucagon and other counter-regulatory hormones or mediators is studied and defined in each case.